Cell Biology of Mammalian Nuclei

Project Summary/Abstract
I have a long-standing interest in chromosome biology, and in recent years this has expanded to cover
multiple aspects of mammalian nuclear cell biology. We are pursuing investigations in two areas, both involving
dramatic protein relocalizations related to human health.
One project is focused on tumor marker protein Ki-67, and how it protects chromosomes. Ki-67 organizes
heterochromatin at the nucleolus during interphase, relocalizes to coat mitotic chromosomes, and is important
for tumor growth and metastasis. We discovered that acute depletion of Ki-67 causes DNA damage during
mitosis, and that defects are more severe when Ki-67 and p53 are simultaneously depleted. We also discovered
that the C-terminal chromatin-binding domain of Ki-67 (termed “LR”, based on its leucine-arginine dipeptide
motifs) is necessary and sufficient to protect cells from damage when endogenous Ki-67 is depleted. Therefore,
we will analyze how Ki-67 protects DNA, and map where in the genome this is most important.
We will determine which LR residues affect its ability to anchor Ki-67 to chromosomes and protect them from
mitotic damage, focused on sites of mitotic phosphorylation and blocks of charged residues. Data from these
cellular function experiments will guide biochemical studies of nucleic acid and nucleosome binding.
Concurrently, we are working collaboratively to solve the structure of the LR-nucleosome complexes. We have
obtained cryoEM data indicating where LR binds the nucleosome surface, and binding studies with mutant
nucleosomes confirm these findings. In addition to biochemical and biophysical investigations, we will determine
whether specific genomic loci are damaged when Ki-67 is lost. To test this, we will take advantage of our finding
that the 3’OH groups at DNA strand breaks caused by Ki-67 depletion can be enzymatically labeled. We will use
this property to generate genome-scale libraries to map the damage at the nucleotide level and we will determine
whether the patterns are cell-type specific.
Macrophages are a critically important cell type in our innate immune system, which must mount rapid
responses to the presence of infectious agents. The speed and importance of these responses make
macrophages an ideal system for studying dynamic events in the mammalian nucleus. We have established a
research project based on our discovery that macrophages relocalize proteins and nuclear bodies related to
RNA splicing in response to interferon-gamma and bacterial lipopolysaccharides, which together promote pro-
inflammatory “M1” differentiation. These rearrangements require specific signaling events, because they are
blocked by inhibition of p38 MAPK kinases and do not occur during anti-inflammatory “M2” differentiation in
response to cytokine IL-4. We are therefore investigating which RNA processing events and protein partners are
the key regulatory molecules related to these nuclear body dynamics during macrophage differentiation.

Public health relevance
Project Narrative We study multiple aspects of mammalian nuclear cell biology related to human disease. One set of investigations uses biochemical and biophysical experiments to understand how proliferation marker protein Ki-67 protects chromosomes from DNA damage. Another set of experiments explores dynamic events in the nuclei of macrophages, evaluating formation of specific RNA and protein clusters when they are stimulated by inflammatory signals.